EXCITATORY AMINO ACIDS IN SCHIZOPHRENIA

To determine whether the concentration in serum of the amino acids, glutamate, glycine, asparate and serine, correlate significantly with their respective concentrations in CSF in schizopheria subjects treated with clozapine.